Non-tuberculous Mycobacteria as triggers of Systemic Lupus Erythematosus

Summary
Systemic lupus erythematosus (SLE) is an autoimmune disease characterized by inflammatory flares and
progressive organ damage. Current treatments, including glucocorticoids (GCs), can lead to increased
susceptibility to infections, particularly non-tuberculous mycobacteria (NTMs). This proposal aims to investigate
the interactions between NTM infections, specifically Mycobacterium abscessus (Mab), and lupus onset/flares,
while considering the impact of GC treatment. Using a preclinical mouse model, we demonstrated that
inhalation of crystalline silica accelerates lupus onset and progression through alveolar macrophage (AM)-
initiated inflammation. To further explore pulmonary inflammation's role in lupus, we employed a novel ex vivo
model using fetal liver-derived alveolar-like macrophages (FLAMs) from lupus-resistant (C57BL/6J) and lupus-
susceptible (B6.SLE1,2,3) mice. Our preliminary results revealed distinct transcriptional and inflammatory
responses between B6.SLE and B6 FLAMs when exposed to various pathogen-associated molecular patterns.
Notably, infection with a specific Mab clinical isolate (Mab41) induced a robust type I interferon response in
B6.SLE FLAMs but not in B6 FLAMs, suggesting that certain bacterial-host genotype combinations may trigger
unique inflammatory responses. We propose that Mab infections are an underappreciated trigger for lupus
onset and flares which is further complicated by GC treatment. To test this prediction directly we will explore
mechanistic interactions between distinct Mab clinical isolates (CIs), lupus progression, and GC therapy. In
Aim1 we will examine the pathogenesis and inflammatory differences of distinct Mab CIs in both B6 and
B6.SLE FLAMs. We will then test how distinct ex vivo outcomes correlate with the loss of immune tolerance
and lupus progression during in vivo infection. In Aim 2 we will determine how GC treatment alters interactions
between Mab CIs, inflammation, and lupus onset. This exploratory proposal will be the first to examine
connections between NTM infection, lupus progression and GC treatment. Our innovative ex vivo and in vivo
models, including a novel oral prednisone diet model, have the potential to fundamentally change our
understanding of how respiratory bacterial infections contribute to autoimmune disease progression.
By exploring these novel connections, we will enhance our understanding of lupus pathogenesis and identify
new avenues for prevention and treatment.

Public health relevance
Project Narrative Systemic Lupus erythematosus (SLE) is an incurable autoimmune disease with both genetic and environmental components, including infectious triggers such as non-tuberculous Mycobacterium (NTM). This project will address key gaps in our understanding of interactions between pulmonary NTM infection, lupus disease, and mainstay glucocorticoid (GC) therapy. Using innovative ex vivo models of lung immune cells and in vivo models of GC treatment we will directly link respiratory bacterial infections with lupus onset to identify potential targets for novel interventional therapies.